Core--Protocol specific research support

Description: Funds are requested to provide support to institutional investigators for selected clinical trials via the Protocol Specific Research Support. This service is designed to assist investigators in Phase I and II study design, implementation, creation of forms and schema design, patient education, collection, handling and shipping of specimens, and data collection. The clinical research coordinators also prepare interim reports for review by investigators.